Endothelial Rap1 in the control of heart function

Cardiovascular disease (CVD) is a global pandemic with over 26 million people affected worldwide. Critical for
regulation of heart oxygenation and metabolism is the cross-talk between heart endothelial cells (ECs) and
cardiomyocytes (CMs) and smooth muscle cells (SMCs). This cross-talk, mediated by locally acting, bioactive
substances released by cardiac ECs (paracrine function), in particular nitric oxide (NO), controls blood flow
and vascular permeability, as well as CMs' growth, contractility and rhythmicity. However, the mechanisms
underlying the functional interaction between cardiac ECs and CMs and SMCs are still poorly understood.
Our pioneering studies on endothelial functions of the small GTPase (Ras Association Proximate) Rap1
highlight its role as novel regulator of vascular homeostasis. Rap1 is critically required for nitric oxide (NO)
production and bioavailability, as tissue-specific deletion of both Rap1 isoforms (Rap1A and Rap1B) leads to
severe endothelial dysfunction. Emerging data from our collaboration strongly suggest that the two Rap1
isoforms in both coronary (vascular) and heart microcapillary (cardiac) ECs may be essential to preserving
normal contractile function of the heart.
Our data demonstrate that EC-specific deletion of Rap1 leads to decreased cardiac contractility and impending
heart failure. Mechanistically, our preliminary data strongly suggest that, via discrete yet complementary
mechanisms, two Rap1 isoforms are essential for endothelial Ca2+handling and endothelial function (NO
production). The goal of this proposal is to examine the role of the two Rap1 isoforms in coronary and cardiac
ECs required for maintenance of cardiac contractile function. We hypothesize that Rap1-dependent EC
functions form the nexus for EC-SMC and EC- CM communication required for normal cardiac function.
Conversely, Rap1 deficiency-driven EC dysfunction (impaired NO release, Ca2+ overload) is the common
culprit in EC–SMC and EC–CM miscommunication that leads to heart failure. To test this hypothesis, we will:
(1) Determine how Rap1 controls Ca2+ homeostasis in ECs; we will utilize patch clamp electrophysiology and
Ca2+ measurements in vitro to examine the effect of Rap1 deficiency on Ca2+ influx channels. We will examine
the effect of impaired Ca2+ homeostasis in Rap1A KO ECs on cellular processes controlling paracrine function.
(2) Examine a novel signaling pathway involving CalDAG-GEFIII-mediated Rap1B activation in NO release. Ex
vivo, we will test the effect of Rap1 signaling and ion channel inhibition on mouse and human coronary vessel
dilation, to determine the influence of EC Rap1A and Rap1B in the control of coronary vessel blood flow.
(3) Examine vascular and cardiac function in EC-Rap1 knockout mice ex vivo and paracrine function in EC-CM
co-culture in vitro to determine how cardiac EC Rap1 isoforms control heart contractile function.
Proposed studies will uncover novel, previously unexpected mechanisms governing heart endothelium and
may lead to a new direction in restoring cardiac function by controlling Rap1 signaling in endothelium.

Public health relevance
PROJECT NARRATIVE The complications of heart failure are major killers of the American population, and incidence is expected to rise by 46% in the next decade. This project will help our understanding of the mechanisms through which endothelial cells in the heart maintain normal heart function, and how defects in these responses contribute to heart failure. These are the first necessary steps in developing new strategies to restore endothelial function to prevent the progression of heart failure.